Hes1-loss promotes dysregulation of epithelial homeostasis and inflammation in a serrated adenocarcinoma model

Distinct from the conventional adenoma–carcinoma pathway, the “serrated
pathway” is a molecular pathway postulated for a subset of CRCs that develop from
some serrated precursor lesions. In addition, inflammation is a known risk factor for
CRC. However, molecular carcinogenic mechanism driving serrated lesion
transformation, which is frequently associated with chronic inflammation, remains an
important knowledge gap. Previously we found that Notch/HES1 expression is lost in
most human sessile serrated adenoma and right-sided CRC, and is a ubiquitous marker
for IBD-associated serrated lesions and CRC. In addition, Notch/Hes1-loss underlies
the gut pathology of an animal model of colitis-associated CRC featuring serrated-like
lesions. In this proposal, we will use a combination of approaches (organoid culture,
molecular and cellular signaling network analysis of human SSA and serrated CRC, and
microbiome deep gene sequencing, etc) and our unique carcinogen-free animal models
to study the mechanism by which HES1-loss disrupts epithelial homeostasis, and
defining how this process cooperates with a pro-tumorigenic cytokine milieu
represented by IL1β to promote carcinogenesis.

Public health relevance
Chronic inflammation is a risk factor for colorectal cancer (CRC). A subset of CRC develops through the “serrated pathway” which often shows characteristic immune microenvironment. In this study, we will use novel colitis-associated CRC models and human specimen cohorts to study how epithelial Notch/Hes1-loss orchestrates a pro- tumorigenic immune microenvironment. The biomarkers identified from studying the pre-malignant forms and inflammation-associated CRC in the serrated pathway will have significant interventional impact.